Does biocompatibility contribute to transfusion-related adverse effects?

Project Summary
Plastics are commonly used to manufacture consumer goods and disposable medical products, nevertheless,
there is increasing concern over the ubiquity of plastics and human exposure to plastic chemical contaminants.
Health concerns are primarily directed toward phthalates, which are used to produce flexible polyvinyl chloride
materials (e.g., blood storage bags, medical-grade tubing), and bisphenols that are used to build resilient
polycarbonate plastics and membranes (e.g., cardiotomy reservoirs, oxygenators, hemoconcentrators). Studies
have shown that plastic chemicals leach from medical products in large quantities. As a result, pediatric patients
can be exposed to these chemicals at levels that exceed safety thresholds by >1,000-fold. Although the direct
effect of these exposures remains unclear – epidemiological studies have reported alarming associations
between plastic chemical exposures and ~40-75% increased risk of all-cause and cardiovascular mortality.
Accordingly, we hypothesize that the postoperative complications experienced by cardiac surgery patients are
likely exacerbated by incidental plastic chemical exposure.
We will use a multipronged approach, with both preclinical models and human data, to test our hypothesis using
the following aims: 1) Elucidate the mechanisms by which plastic chemical exposures contribute to cardiac
dysfunction. 2) Determine the extent to which plastic chemicals impact red blood cell quality and tissue
oxygenation in the context of cardiac surgery. 3) Evaluate the risk of plastic chemical exposures in pediatric
cardiac surgery patients.
Results of this study will influence the clinical care of ~25 million patients/year receiving critical care via medical
procedures that employ plastics, including heavily transfused patients. Knowledge established by this study will
inform and incentivize the adoption of alternative materials, and prompt manufacturers to utilize new fabrication
techniques, surface coatings, or alternative chemicals for medical and consumer products. Further, the results
of this study can serve as preclinical guidance for a future randomized clinical trial in which patients are assigned
to different mitigation strategies to reduce chemical exposures (e.g., red blood cell washing or ultrafiltration to
remove contaminants, non-phthalate or non-bisphenol medical products). Finally, the knowledge gleaned from
this work can be applied to broader public health concerns regarding daily environmental plastic chemical
exposures and links to chronic health conditions, including cardiovascular and cardiometabolic disorders.

Public health relevance
Project Narrative Blood transfusions are a life-saving intervention – but this intervention is also linked to postoperative complications in cardiac surgery patients. We propose that such complications are related to chemical contaminants that are used to store, circulate, and transfuse blood products. Using both experimental models and human data, we will evaluate the risk of plastic chemical exposures and evaluate the safety of potential chemical alternatives.